Molecular consequences of microtubule bending in living cells

Project Summary/Abstract
The overarching goal of the Nihongaki group is to decipher the molecular consequences and functional
implications of microtubule bending in living cells. We will achieve this by creating innovative molecular tools
that can manipulate target molecular processes with precision. Microtubules play a crucial role in vital cellular
processes, including cell division, cell migration, and cell polarity. Consequently, defects in microtubules, such
as mutations in proteins associated with microtubules, are often linked to a variety of human diseases,
including cardiovascular and neurological disorders. At a molecular level, microtubules are cylindrical filaments
made up of alpha and beta tubulin dimers. Because of their high rigidity, microtubules reconstructed in vitro
grow in a straight line and are readily broken by mechanical stress. In contrast, cellular microtubules are often
bent without significant breakage, and the molecular consequences of microtubule bending in living cells
remain largely elusive. Does microtubule bending damage the lattice of microtubules in cells? How do cells
grant microtubules mechanical resilience in response to their bending? Is microtubule damage induced by
bending stress repaired? To address these fundamental questions, our research program for the next five
years will concentrate on investigating the molecular events occurring on bent microtubules in living cells. This
will be facilitated by the development and implementation of a novel genetically encoded tool for inducible
control of microtubule bending. By combining this microtubule bending technique with fluorescence microscopy,
genetic and pharmacological perturbation, and other molecular tools, we will comprehensively illuminate the
molecular response to microtubule bending in living cells: curvature-induced microtubule damage, local
microtubule protection by tubulin acetylation, and lateral repair by fresh tubulin incorporation. This research will
provide new mechanistic insights into microtubule maintenance in living cells, potentially leading to novel
therapeutic strategies for microtubule-related diseases.

Public health relevance
Project Narrative Due to their significant involvement in essential biological processes, disorganization of microtubule networks is often associated with a diverse range of human diseases, from heart disorders to neurodegeneration. This project aims to advance our understanding of how cells protect microtubules from mechanical stress-induced breakage. The successful completion of this project will provide novel insights into microtubule biology, potentially leading to the development of therapies for these microtubule-related diseases.